NIGMS Administrative Supplements to Support Undergraduate Summer Research

Administrative Supplement to Parent Grant R01 GM128145 Addressing Open Challenges of Computational Genome Annotation PI Mark Borodovsky Abstract Improving gene finding in eukaryotic genomes is a large and important part of the parent proposal. With Andrey Zaznaev, the Georgia Tech Deans’s list junior student, who is very interested in making contribution in computational biology, we will work on additional aim of the proposal ? developing an improved algorithm for gene prediction in eukaryotic genomes that are distinguished by their complexity - long- and short-range inhomogeneity of genome GC composition. The undergraduate student will create tools for generating a library of GC- dependent models of protein-coding regions in each genome. He also will develop an extension of the gene finding algorithm that will be able to use the new models.

Public health relevance
Administrative Supplement to Parent Grant R01 GM128145 Addressing Open Challenges of Computational Genome Annotation PI Mark Borodovsky Project Summary: PI will be involved in design, implementation and testing of all algorithms described in the Supplement proposal. Andrey Zaznaev, undergraduate student will work on implementation of the algorithms solving tasks described in Aim 1a, debagging the new software as well as testing the code performance on control sets of sequences provided by collaborators and by Georgia Tech.